Novel Neuromodulation Treatment of Age Related Vestibular Loss to Improve Balance and Gait in Elderly Individuals

Abstract
Loss of neural function is a common problem with aging and disease. To treat this loss, current
neural stimulators have used various forms of stimulation that putatively activate neurons to
elicit neuromodulation. Generally these stimulators rely on a fixed frequency and amplitude
stimulus. Recently, we have found that subperceptual levels of random electrical stimulation
applied to the vestibular system produce improvements in vestibular-mediated reflex function,
balance and gait demonstrating the use of low levels of electrical stimulation to enhance the
natural neural signaling of the vestibular system without exogenous stimulus. The goal of this
present work is to demonstrate the sustained improvement of balance and gait by applying low
levels of random electrical stimulation to the vestibular system of elderly individuals with
vestibular hypofunction. We hypothesize that elderly participants will display functional
improvement with sustained low levels of random electrical stimulation. This work will establish
parameters for viable treatment of age related vestibular loss in elderly individuals using safe
and effective amounts of electrical stimulation.

Public health relevance
Project Narrative Loss of vestibular function with aging affects both balance and gait and is thought to contribute to increased fall risk. Recently, we have found that very low levels of random electrical stimulation applied to the vestibular system produce improvements in vestibular function along with balance and gait measurers in elderly individuals with age related vestibular loss. The present work aims to test if this novel subperceptual neuromodulation stimulus can be used as an effective treatment for age related vestibular loss that will improve balance confidence, balance and gait, in the hopes of reducing fall risk.